Investigating mechanisms of microvesicle release and function by GDE2 and GDE3

Project Summary / Abstract
Extracellular vesicles (EVs) are small membrane bound vesicles released by cells that have recently emerged
as central players for many aspects of human health, including AD. However, these initial studies have raised
conflicting data about whether EVs are neuroprotective or pathogenetic. EVs can be broadly divided into
exosome and microvesicles (MVs), and work in other fields suggests that EV subtypes can play specialized
roles. Accordingly, more work is needed to characterize subtypes of EVs in the central nervous system (CNS)
and determine if these have neuroprotective or pathogenetic functions. Our lab has identified the six-
transmembrane enzymes GDE2 and GDE3 as novel releasers of MVs. Preliminary and published studies ascribe
GDE2 and GDE3 roles in regulating neuronal survival and indicate that GDE2 distribution and function are
disrupted in Alzheimer's Disease (AD). This proposal will test the central hypothesis that GDE2 and GDE3 utilize
a unique biosynthesis pathway to release MVs that have neuroprotective function, and that this release pathway
is disrupted in AD. Specifically, this proposal will separately examine the MV biosynthesis pathway of GDE3 and
GDE2 (Aim 1) and identify protein and RNA cargo of GDE2 and GDE3 EVs (Aim 2). Experiments in Aim 3 will
characterize the disruption of GDE2 localization and MV release in AD, and asses the neuroprotective
capabilities of GDE2 MVs in vitro. Successful completion of this project will characterize the biosynthesis and
function of novel subtypes of EVs in the CNS and determine if they are perturbed in AD. The proposed project
will provide excellent training for me in research. Specifically, I will gain new experiences in the fields of EV
biology and neuroscience and gain new expertise across multiple techniques that include EV isolation and
biochemical analysis, proteomics and deep sequencing, bioinformatics, mouse genetics, primary cell-culture,
viral transduction, and human disease. The research environment is highly collaborative, I will have multiple
opportunities to mentor and teach, and develop my scientific presentation skills though presentations and
publications. Overall, this Kirschstein-NRSA grant will not only provide new insight into fundamental EV biology
and explore relevance to AD, but will also prepare me for my future career as an independent investigator.

Public health relevance
Project Narrative Extracellular vesicles (EVs) play critical roles in maintenance of health and are commonly disrupted in disease including Alzheimer's Disease. Proposed studies will describe the production and content of a unique subtype of EV produced in the brain and determine if these EVs play a role in neuroprotection or Alzheimer's Disease. Understanding basic pathways that mediate neuroprotection and how the process goes awry in disease can help in identification of novel therapeutic approaches and biomarkers.